16th Fellows Forum on Osteoporosis and Metabolic Bone Disease

This application seeks support for the 16th Fellows Forum on Osteoporosis and
Metabolic Bone Diseases. The conference will be held September 7-9, 2022,
immediately prior to the Annual Meeting of the American Society of Bone and Mineral
Research in the Austin Convention Center, Austin, Texas. The program will also be held
virtually and using a virtual platform. We expect to have approximately 90 postdoctoral
trainees who are united by their research interests but who are training in a number of
different basic and clinical specialties. The faculty will consist of 12 of the most highly
valued thought leaders in the world. The ability of young investigators with promise to
interact with this faculty in a setting of both didactic and interactive workshops has been
and will continue to be a seminal experience, leading to a further commitment on the
part of these fellows to train in osteoporosis and other metabolic bone diseases.

Public health relevance
The application seeks support for the 16h Fellows Forum on Osteoporosis and Metabolic Bone Diseases that will be held at the Austin Convention Center, Austin, Texas, September 7-9, 2022